White matter protection by inhibitors of glial scar formation in perinatal hypoxia ischemia

Summary
By adulthood, survivors of premature birth are at significantly increased risk for several forms of severe mental
illness, including nonaffective psychosis, schizophrenia, major depressive disorder, and bipolar affective
disorder. This preclinical research proposal seeks to define the role of sex-dependent factors that influence
early life Extra Cellular Matrix (ECM)-mediated mechanisms that contribute to risks for mental illness in survivors
of premature birth as they mature to adulthood. Our proposal thus aligns with strategic goals 1.1. and 1.4 of
the 2019-2023 Trans-NIH Strategic Plan for Women's Health Research. We propose to define basic
biological differences between male and female neonates that influence mechanisms relevant to enhanced risks
for life-long mental illness in preterm survivors. During preterm neonatal brain development, we have found that
the hyaluronic acid (HA) backbone of the ECM undergoes remodeling by the enzyme TSG-6 (TNF stimulated
gene-6), which displays peak activity. Our preliminary studies support that remodeling of ECM HA by TSG-6
regulates transcriptional maturation of astrocytes which are integral to neuronal function. In knock out mice that
lack TSG-6 activity, adults display alterations in anxiogenic and sensorimotor behaviors in a sex-dependent
fashion. We have further identified that TSG-6-/- mice display disrupted expression of key regulators of
glutamatergic signaling, which we propose are integral to the developmental maturation of neural circuitry
underlying these neurobehavioral disturbances. We hypothesize that TSG-6-mediated remodeling of HA in the
neonatal brain influences sex-dependent maturation of metabotropic glutamate receptors, glutamate
transporters and synaptic spines, which regulate neurotransmission. This proposal will allow us to increase
sample size of both males and females to increase statistical power to analyze for sex differences. We will
determine key mechanisms by which TSG-6-mediated remodeling of HA in the neonatal brain influences sex-
dependent maturation of glutamate receptors, transporters and synaptic spines, which regulate
neurotransmission. In aim 1, we will determine whether abnormal expression of glutamatergic signaling
regulators in TSG-6-/- brains is sex- and age-dependent. We will analyze the sex- and age-dependent expression
of metabotropic glutamate receptors and glutamate transporters including GLT-1, which our preliminary studies
found to be dysregulated in TSG-6 null brains. In aim 2, we will determine whether reduction in soma size of
TSG-6-/- cortical pyramidal neurons is accompanied by sex-dependent changes in dendritic arborization and
spine density in adults. These studies will facilitate our long-term objective to define key cellular and molecular
modifications regulated by ECM HA remodeling that influence neuron-astrocyte homeostasis and behavioral
outcomes. Our TSG-6-/- animals provide a novel model to address significant gaps in our mechanistic
understanding of the sex-dependent regulation of neuronal maturation at critical windows in early brain
development that appear to influence later neurobehavioral phenotypes and risk for mental illness in adults.

Public health relevance
Narrative Although advances in newborn intensive care have markedly improved survival of preterm babies, by adulthood preterm survivors are at significantly increased risk for several forms of severe mental illness, including schizophrenia, major depression and bipolar disorders. This proposal focuses on our recent findings that appear to link sex-dependent changes in brain behavior to a novel enzyme (TSG-6) that acts in the preterm brain to influence the regulation in adults of the glutamate neurotransmitter system, which has been linked to major mental health disorders. We expect these studies to provide new insights to understand and treat the causes of life-long enhanced risk for mental illness in survivors of premature birth.